DIETARY SODIUM, RACE AND CARDIOVASCULAR RESPONSES IN BORDERLINE HYPERTENSION

The purpose of this study is to examine the effects of differing levels of dietary sodium on cardiovascular responses to stress in white normotensive subjects aged 18-28 and 55-70 years old. This will determine whether subjects at risk for hypertension exhibit augmented vascular reactivity to a vasocontrictive stimulus during sodium loading.